Human Pancreas Analysis Program for Type 2 Diabetes (HPAP-T2D)

Human Pancreas Analysis Program for Type 2 Diabetes (HPAP-T2D)
Abstract
Building on our existing infrastructure and scientific collaborations, and the expertise gained
during the first four years of the HPAP effort for Type 2 Diabetes, we have assembled five cores
with expertise ranging from pancreas procurement and islet isolation to data integration. These
Cores form the comprehensive and integrated Penn Human Pancreas Analysis Program – T2D.
Core A will procure a spectrum of human pancreata and detailed donor medical history; isolate
islets; and distribute islets and tissues to the other Cores for further analysis or processing. Core
B will perform physiological phenotyping by perifusion assay, calcium imaging, and oxygen
consumption on the isolated islets. Core C will process tissues using multiple modalities that will
allow for analysis using advanced technologies such as multiplexed immunofluorescent staining
and whole slide imaging. This Core will also archive tissues, DNA and blood for future use and
deliver pathological evaluations of the tissues. Core D will perform multiple advanced modalities
for the molecular profiling of isolated islets including RNAseq, and DNA methylome analysis of
sorted islet cell populations; single cell ATACseq and RNAseq, flow mass cytometry for single
cell quantification of more than 30 cell surface and intracellular markers, and spatial
transcriptomics. Finally, Core E will assemble, annotate and maintain an open-access database
for the Program and its member-researchers, and collaborate with HIRN in the sharing of data.
The entire program will directed by an Executive Committee consisting of the core leaders and
the contact PI, who will be the interface with HIRN and NIDDK leadership. HPAP-T2D will provide
physiologic, genomic, genetic, and histological analysis of the pancreas in type 2 diabetes at
unprecedented detail, share the rich data with researchers world-wide before publication, and
thus enable breakthrough discoveries in our understanding of this disease that has reached
epidemic levels world-wide.

Public health relevance
Human Pancreas Analysis Program – T2D Narrative The past decades have seen a dramatic improvement in our ability to phenotype and molecularly profile human tissues relevant to the etiology of type 2 diabetes with unprecedented resolution, at the genomic, epigenomic, protein, and functional levels. Here we will employ state-of-the-art technologies to determine all aspects of pancreas biology as it pertains to type 2 diabetes, profile human pancreatic islets with multiple assay modalities, and make the vast data accumulated available through the open-access PANC-DB database and website. This comprehensive profiling of the natural history of Type 2 diabetes will pave the way for future discoveries of new treatment modalities for diabetes.